The role of ATM in the suppression of lymphoid malignancy

PROJECT SUMMARY/ABSTRACT
This proposal aims to identify the mechanisms by which ATM kinase suppresses lymphomagenesis. ATM is a
tumor suppressor. Germline ATM defects cause Ataxia-Telangiectasia (A-T) syndrome with a 25% lifetime risk
for lymphomas. ATM is also the 3rd most frequently germline mutated gene in cancers. Somatic inactivation of
the 2nd allele is found in up to 50% of Mantel Cell Lymphomas and 4-8% of common epithelial cancers. In vitro,
both DNA damage and reactive oxygen species (ROS) can activate ATM kinase. In the past two funding cycles,
we investigated how ATM suppresses lymphomas via its role in DNA damage response (DDR). Using mouse
models carrying ATM null, kinase-dead (KD), or missense mutations, we identified a structural function of ATM
that is regulated by its kinase activity. As such, the expression of KD ATM leads to embryonic lethality, while
complete loss of ATM (null) is compatible with development. Moreover, compared to A-T syndrome with little or
no ATM expression, ~ 70% of ATM mutated cancer expresses inactive ATM proteins, imposing a different
lymphoma risk than the null mutation. Mechanistically, we showed that ATM exchanges rapidly at DNA damage
sites, and its exchange is coupled with catalysis. Thus, inactive ATM protein physically blocks DNA repair and
causes hypersensitivity to TopoI inhibition. Several ongoing clinical trials are designed to target ATM-mutant
cancers with TopoI inhibitors. During these studies, we found that Atm-R3008H mutation abolishes DSB-induced
but not ROS-induced ATM activation and displays delayed lymphomagenesis, suggesting Atm’s role in oxidative
stress response might also contribute to tumor suppression. Thus, we propose investigating how ATM
regulates tumorigenesis by modulating oxidative stress responses. ROS activates purified ATM via
intermolecular disulfide bonds. But whether ROS activation of ATM contributes to tumor suppression remains
unknown due to 1) the lack of seperation-of-function mutation to study ATM ROS function during tumorigenesis;
2) ROS damages DNA, confounding DSB vs. ROS induced ATM function; 3) high oxygen in tissue culture
stressed Atm-/- cells (20% O2 vs. 5% in blood). Here, we reported that loss of SLC7A11 (a system xC- antiporter
critical for suppressing ferroptosis), but not Nrf2 (the master transcriptional regulator of oxidative response)
delays lymphomagenesis in Atm-/- mice by >200 days without affecting chromosomal translocations, revealing a
vulnerability of Atm-deficient cells to ferroptosis, non-apoptotic cell death by membrane lipids peroxidation and
rupture. Moreover, we found that Slc7a11 is uniquely expressed among immature T cells. Based on these, we
hypothesize that Atm regulates ferroptosis vulnerability to suppress immature T-cell malignancies. To test
it, we will study how 1) SLC7A11 loss delays Atm-deficient thymic lymphomas, 2) ATM regulates ferroptosis
sensitivity, and 3) whether ferroptosis can target ATM-deficient cancers and T-ALL without ATM mutations. The
results will reveal the physiological link between ROS-induced ATM activation and tumor suppression and
provide new strategies to target T-ALLs and ATM-mutated cancers.

Public health relevance
PROJECT NARRATIVE Our proposed study 1) how SLC7A11 deletion and ferroptosis prevent the transformation of Atm- deficient lymphocytes and other cancer cells; 2) how ATM promotes ferroptosis in T cells and in general; 3) whether T-ALLs and other ATM-deficient cancers are sensitive to ferroptosis inducers. The results will reveal the physiological functions of ATM in ROS responses and tumor suppression and identify new vulnerabilities of T-ALL and activating T cells with implications for cancer therapy and immuno-oncology application of ROS regulators.